Synthetic circuit technologies for precision control and signal processing in mammalian cells

PROJECT SUMMARY
Synthetic gene circuits that enable precise, customizable control of gene regulation and human cell function can
address unmet needs in biology, medicine, and synthetic biology, ranging from next-generation cell-based
therapies to programming tissue function. However, the lack of engineering toolkits that provide robust in vivo
activity, clinically-suitable compositions, and easy implementation for implementing gene circuits in biomedically-
relevant human cell types has drastically limited our ability to realize these important biomedical goals. To
overcome these limitations, our collaborative team recently established a powerful set of toolkits that enable the
construction of “clinically-optimized” synthetic circuits for (FDA-approved) drug-inducible and cell-autonomous
control of therapeutic human cell function. Using these toolkits, we already succeeded in engineering advanced
control of primary human T cells, such as programming T cells to recognize multi-faceted features of target cells
and launch complex, multi-tiered therapeutic actions – foundational work that serves as the basis of a recently
launched clinical trial for next-generation cellular therapy. In this project, we will expand our gene circuit
engineering capabilities in critical new directions – toward engineering precise control of human macrophage
and coordinated multi-immune cell functions – through the development of monocyte/macrophage-optimized
toolkits. Macrophages are functionally versatile cell types that play central homeostatic roles in nearly all tissues.
Additionally, macrophages have a number of unique properties that make them promising tools for potential cell-
based therapies, including their natural ability to migrate into tumors and their ability to phagocytose cells and
interface with the adaptive immune system through antigen presentation. However, engineering macrophage
function through synthetic biology-based methods remains nascent and technologically underdeveloped. We will
address this unmet need through three independent Aims. First, we will develop macrophage-optimized toolkits
of synthetic humanized transcription factors and transcriptional receptors for programmed gene regulation,
enabling the construction of circuits for localized, signal-dependent production of immune effectors and payloads
in vitro and in vivo. Second, we will establish a novel, high-throughput pipeline to generate and screen
engineered macrophage receptors with customizable phagocytic and immune activation functions. Finally, we
will demonstrate novel circuit types that allow macrophages to coordinate their responses with endogenous
and/or engineered T cells to drive synergistic and amplified immune functions, thus establishing the basis for
engineering multicellular immune networks. Together, this work and our toolkits, which will make freely available
to the academic scientific community, will substantially expand the capabilities of mammalian cell engineering
and usher in an exciting era of macrophage cell-based biotechnologies with broad biomedical and therapeutic
applicability.

Public health relevance
PROJECT NARRATIVE Methods that allow scientists to engineer mammalian cells to execute desired cellular functions in response to defined biological and chemical signals offer tremendous potential for biomedical research and for creating next- generation cell-based biotechnologies and therapeutics. However, existing tools face significant limitations – for example, they do not offer clinically-suitable compositions, robust activity, and easy implementation across biomedically-relevant human cell types. To address these limitations, we propose to develop advanced synthetic biology tools to control gene regulation and cell function, and to apply these tools to engineer a variety of clinically-relevant human immune cell types, with broad applicability including potential therapeutic applications for cancer.